METHOD DEVELOPMENT FOR DETERMINATION OF TRACE ANTIGENIC PEPTIDES

The ability to separate, quantify, and determine structure of trace levels of Class II antigenic peptides allow research to be expedited in fundamental immunology. We are exploring immuno-affinity coupled with reverse-phase HPLC, micro HPLC, nano HPLC and ion exchange coupled with micro HPLC to separate antigenic peptides from other closely related peptides. Identification will be either by matrix-assisted laser desorption ionization, monitoring post-source decomposition's, or by HPLC and the ion trap using electrospray or nano-electrospray (Finnigan LCQ). We also seek to develop methods for quantification of complex peptide mixtures by MALDI.